STRUCTURE OF CLATHRIN CAGES BY STEM AND METAL REPLICATION

Methods are being established to characterize the structure and assembly of clathrin triskelions and clathrin cages in vitro to help our understanding of the energetics of receptor-mediated endocytosis. Preparations of the clathrin macromolecular assemblies in various buffers were adsorbed onto thin carbon substrates supported on EM grids, then rapidly frozen in liquid ethane at -180 degrees C. Specimens are either cryotransferred into a high-resolution field-emission STEM for measurement of molecular-weight distributions, or cryotransferred into a vacuum chamber for freeze-etching and platinum/carbon shadowing. It has been necessary to determine the conditions for freeze-drying and metal shadowing to achieve optimal resolution. The metal replicas are imaged digitally in a transmission electron microscope equipped with a slow-scan cooled CCD camera controlled by a Power Macintosh computer. Digital electron microscopy has the advantage of providing immediately accessible data without the need for a dark room.